Micronutriomics for Population-Level Women, Infant, and Child-focused Public Health Interventions

1 Project Summary/Abstract
2
3 Omic methodologies can improve our understanding of the metabolic, proteomic and genomic
4 consequences of micronutrient deficiencies and interventions in undernourished populations including
5 pregnant women, children and adolescents. Specifically, this conference will examine the use of new
6 omic technologies and methods to assess the effects of nutritional status on health; improve
7 assessment and interventions; and broaden knowledge on the impact of nutrition on pregnancy and
8 fetal, child and adolescent growth and development. The use of omics to detect the impact of
9 micronutrient interventions will result in tremendous public health learnings related to pregnancy
10 outcome and child development.
11
12 Low intakes of many micronutrients are common in many underrepresented populations, resulting in
13 chronic, marginal deficiencies which may not produce clinical symptoms, but likely cause underlying
14 metabolic changes that are difficult to identify. Similarly, micronutrient interventions, either with single
15 or multiple micronutrients, are likely to cause myriad metabolic changes of consequence to health that
16 are not yet identified. Omics is a powerful tool that will elucidate the effects of micronutrient
17 deficiencies and interventions at the population level. Little is known about subclinical and/or marginal
18 micronutrient deficiencies on metabolism and health of underrepresented populations, or the effects of
19 micronutrient interventions on the metabolome, the genome or the proteome. Given the enormous
20 ongoing efforts in micronutrient supplementation and fortification world-wide, these are critical
21 knowledge gaps. Convening experts in omics and experts in population-level micronutrient nutrition
22 research and intervention programs and the planned collaborative discussions will highlight future
23 joint research opportunities, as well as available samples and analyses, for both basic and applied
24 investigators in the area of public health nutrition specific to maternal and child health. The conference
25 will allow researchers to prioritize existing samples and analyses of maternal and birth to 24-months
26 populations that are available and identify investigators who will lead future omics analyses. Through
27 omics, we can understand and improve outcomes of global public health importance related to high-
28 risk pregnancy, child and adolescent growth, wasting, stunting, inflammation, maternal and child
29 survival, and disease prevention.

Public health relevance
Project Narrative Overall, this conference will lead to a better understanding of the complex biology of nutrition and nutrition’s effects on maternal and child health using a systems-based approach. The conference findings will increase knowledge of the molecular and cellular roles of nutrients as the basis of human development and, therefore, advance safe and effective public health approaches to protect the health of pregnant and lactating women and children. By using omics technologies, we will better identify populations at risk for micronutrient deficiencies and their specific nutritional risk factors to enhance target interventions.